PARTICLE SIZE DISTRIBUTIONS OF NEBULIZED DRUGS

Recombinant alpha 1-antitrypsin is currently administered intravenously in the treatment of cystic fibrosis. A new protocol has been designed to treat these patients via aerosol so as to deliver large doses of alpha-1 antitrypsin directly to the respiratory tract. We will study the particle size distributions of several nebulizers to ensure that the proper particle size (1-3 microns) is being delivered to the patient. The Misty, Retec, and Vortran nebulizers will be evaluated using a commercially available instrument such as the Malvern, TSL, or In-Tox particle sizer. In the future, the size distribution of other aerosolized drugs will be evaluated for patient therapy.